RECEPTOR INDUCED ACTIVATION IN LYMPHOID CELLS

The objectives of this research program are to study the sequence of cellular and molecular events initiated by antigen receptor perturbation and which culminate in T cell activation. These objectives will be accomplished by the techniques of differential nucleic acid hybridization in order to isolate genes that are transcriptionally active as a result of antigen receptor-induced activation. The development of cDNA probes from these genes will allow detailed analysis of T cell activation kinetics and stimulus-response coupling in this critical immunoregulatory cell as well as the identification of previously uncharacterized lymphokines. Aberrant and inappropriate T cell activation has a central role in the etiology of a variety of autoimmune, neoplastic, and hematologic disorders. Delineation of the mechanisms and consequences of immune T cell recognition of antigen will permit the development of novel strategies for specific immunotherapy based on a more complete understanding of the T cell activation sequence.